Mechanisms of Disease and Treatment in Novel Metabolic Developmental Brain Disorders

PROJECT SUMMARY
We have recently identified a novel human neurogenetic disorder caused by loss-of-function mutations in the
mitochondrial enzyme glutamate pyruvate transaminase 2 (GPT2). Genetic metabolic diseases, such as GPT2
disease, offer a powerful lens to investigate mechanisms of metabolism in human brain. Also, metabolic
diseases may be amenable to treatments via dietary restrictions or supplements. GPT2 disease involves
postnatal undergrowth of brain and progressive spastic paraplegia. Based on our extensive preliminary data,
we have established potential treatment strategies for GPT2 disease. To guide these interventions in children,
we propose to complete needed pre-clinical studies. GPT2 localizes to mitochondria and is upregulated during
postnatal brain development. GPT2 catalyzes the reversible addition of an amino group from glutamate to
pyruvate, yielding alanine and a-ketoglutarate, a metabolite in the tricarboxylic acid (TCA) cycle. Our
preliminary data provide support for disease mechanisms, wherein GPT2 plays a critical role in neuronal
growth by regulating neuronal alanine synthesis and anaplerosis. Anaplerosis (filling-up) is the metabolic
process whereby TCA cycle intermediates are replenished. Anaplerosis is important during high biosynthetic
demand, when TCA cycle intermediates are consumed for synthesis of macromolecules for cell growth, a
process known as cataplerosis. Therefore, the central objective of this R01 application is to define the role of
GPT2-mediated mechanisms in neuronal development and health, and to study the efficacy of mechanism-
based treatments. Aim 1 is focused on in vivo studies of Gpt2-mediated growth of motor neurons. Our Gpt2-
null mouse recapitulates key aspects of disease, such as hindlimb motor abnormalities, akin to spastic
paraplegia seen in patients. In Aim1 and in Aim 2, we are developing mechanism-based rescue strategies to
treat motor defects in vivo through metabolite supplementation in the diets of Gpt2-null animals. Aim 3 will
define GPT2-mediated metabolic mechanisms governing neuronal growth and treatments in vitro. These
studies are in both primary mouse neurons, as well as in human neurons (from stem cells) in order to translate
advances back to the human context. We have a strong and multidisciplinary team permitting a powerful
integrated translational approach, bridging patient-oriented studies to experimental models. In summary,
research in this proposal will have a sustained impact on both fundamental neuroscience and treatment
development. We will evaluate therapeutic strategies that could be rapidly implemented in patients with GPT2
disease, which currently has no known treatment. This progress would pave the way for early intervention, and
potentially, prevention of neurologic damage in patients with GPT2 disease. Finally, these studies have broad
significance, as we will define basic metabolic mechanisms required for growth and health of long-projecting
neurons, including long-projecting motor neurons that are vulnerable in a variety of neurological diseases.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health, as we will conduct pre-clinical studies of mechanism-based treatments for a new neurogenetic metabolic disorder. The disease mechanisms being studied also have broad relevance to the health of long-projecting neurons, such as those involved in a variety of neurological diseases.